Influence of a supervised postpartum exercise program on maternal physical activity levels and musculoskeletal health

Abstract
Physical activity (PA)/exercise is crucial for maternal health and wellbeing but several barriers to
PA/exercise participation exist in the postpartum period. Musculoskeletal impairments—such as
weakness, increased fatigability, pelvic ﬂoor dysfunction (e.g., incontinence, pelvic organ prolapse,
etc.), and pain—are common in the postpartum period. While these impairments provide strong
rationale for participation in PA/exercise, they can also act as barriers to participation. Several
psychosocial barriers also exist, including fear of movement and lack of childcare. Despite the
importance of PA/exercise for health and wellness, and the documented musculoskeletal
impairments that are associated with the postpartum period, assessment of neuromuscular
function and education on resuming exercise is lacking in the standard postpartum care model in
the United States. In addition, conﬂicting information can be found on social media and among
clinical experts on when and how to best resume PA/exercise after childbirth. This proposal will
evaluate the inﬂuence of an eight-week exercise intervention on neuromuscular function (i.e., lower
extremity strength & endurance, pelvic ﬂoor muscle strength & endurance, self-reported pelvic
ﬂoor dysfunction symptoms), habitual physical activity levels, and overall wellbeing (i.e., levels of
kinesiophobia, sleep quality, self-reported quality of life) in postpartum females. In an effort to
decrease barriers to exercise, childcare will be offered, and participants will have the opportunity to
incorporate their child(ren) into exercise sessions if they so desire. This proposal will utilize a
randomized control trial (RCT) design and objective measures of strength (i.e., load cells) along with
standard clinical assessments of pelvic ﬂoor muscle function (i.e., internal vaginal assessment of
strength and endurance, self-reported symptoms using validated questionnaires). Findings will be
used to perform power analyses for future grant proposals to support a large, appropriately
powered RCT. This proposal has potential to signiﬁcantly inﬂuence guidelines for postpartum
physical activity/exercise, thus facilitating a change in current standard postpartum care.

Public health relevance
Project Narrative The postpartum period is associated with decreases in physical activity levels, muscular strength, muscular endurance, and pelvic ﬂoor muscle function, but little scientiﬁc evidence exists on how best to initiate and progress exercise in the postpartum period. This proposal aims to improve habitual physical activity levels, neuromuscular health (i.e., strength, fatigability, symptom burden) and overall wellbeing (i.e., decreased fear of movement, improved sleep quality, improved perception of quality of life) through participation in a weekly exercise program. This study will help to inform postpartum exercise recommendations and is novel as it allows participants to incorporate their children into the exercise routine, thus removing a primary barrier to physical activity/exercise.